Molecular Genetics Of Scrapie Pathogenesis

Transmissible spongiform encephalopathies (TSE) are a group of rare neurodegenerative diseases which include Creutzfeldt-Jakob disease (CJD) in humans, scrapie in sheep, bovine spongiform encephalopathy (BSE) and chronic wasting disease (CWD) in mule deer and elk. TSE infectivity can cross species barriers. The fact that BSE has infected humans in Great Britain and concerns that CWD may act similarly in the US underscores the importance of understanding TSE pathogenesis and developing effective anti-TSE therapeutics. The precise nature of the infectious agent of the TSE diseases is unknown. Susceptibility to infection can be influenced by amino acid homology between a normal host protein (PrP-sen) and the abnormal proteinase K-resistant form of this protein, PrP-res. Formation of PrP-res is closely associated with infectivity and PrP-res is a primary component of the TSE infectious agent. An understanding of how this protein is made is critical for our understanding of TSE pathogenesis and for devising therapeutic strategies to prevent its synthesis. My studies address many different aspects of the TSE diseases at both the molecular and pathogenic level. In particular, my laboratory focuses on: 1) identifying the earliest events which occur during TSE infection, 2) precisely defining the different cellular compartments where PrP-res formation occurs, 3) determining the molecular basis of TSE strains and, 4) development of effective therapeutic TSE agents. In 2010, we utilized a LC-MS/MS Nanospray Ion Trap Mass Spectrometer to study PrP-res purified from different scrapie strains in order to determine if there were proteins uniquely associated with a given TSE strain that could contribute to TSE strain-specific phenotypes. Although multiple proteins were identified that co-purified with PrP-res, none were specific to any given scrapie strain. The results suggest that TSE strain phenotypes are not determined by non-PrP protein factors. Our study is the first to utilize a proteomics approach to study multiple TSE strains. In 2010, we have also continued to develop both unique reagents and new experimental model systems that will allow us to follow the course of acute TSE infection in vivo and in vitro.